Dual targeting chemokine receptors prevents chemotherapy-induced cardiotoxicity

Doxorubicin (DOX) is an effective chemotherapeutic drug to treat cancer. However, DOX-induced cardiotoxicity
(DICT) has limited its use. Dexrazoxane is the only current FDA-approved agent for preventing DICT, but its
cardioprotective effect is incomplete and the side effects also limit its use. Thus, the search for new
cardioprotective agents for DICT continues. SDF-1 and its receptor CXCR4 play essential roles in cardiovascular
development and diseases. Constitutive loss either one of them results in perinatal lethality partially due to
cardiac septum defects. Myocardial supplement of SDF-1 attracts stem cells that express CXCR4 to the site of
injury to promote cardiac regeneration and angiogenesis. However, their roles in cardiovascular system remain
controversial. For instance, heterozygous deletion of CXCR4 in mice reduced infarct size and CXCR4
overexpression increased infarct size and reduced cardiac function along with excessive cardiac inﬂammatory
cell infiltration. CXCR7 is a lately identified second receptor for SDF-1. CXCR7 binds SDF-1 with an affinity about
ten times higher than CXCR4 and it can either positively or negatively affect SDF-1/CXCR4 axis-mediated
functions. This raises a concern as to how to distinguish the roles of SDF-1/CXCR7 from SDF-1/CXCR4 in
cardiac protection. We showed that SDF-1 prevents cardiac lipotoxicity through CXCR7 but not CXCR4. A single-
cell RNA-seq analysis revealed the most abundant expression of CXCR7 in cardiomyocytes and cardiomyocyte-
specific CXCR7 deletion showed more prominent cardiac dysfunction after myocardial infraction, suggesting an
essential cardiac protection. Given the protective effects of CXCR7 in cardiomyocytes and the harmful effects of
CXCR4-mediated cardiac excessive inflammation, we tested the protective effects of a dual targeting compound
with specific antagonistic activity against CXCR4 and potent agonistic activity on CXCR7, against DICT. We
found this compound treatment significantly prevented DOX-induced cardiac dysfunction, cell death,
inflammation and fibrosis, along with upregulation of signals involving in cardiac energy reserve metabolic
process and downregulation of signals involving in mast cell infiltration and activation, but without affecting the
suppressive effects of DOX on tumor growth. We thus hypothesize that dual targeting compound prevents
DICT by activating cardiac CXCR7 to reprogram cardiomyocyte metabolism and prevent cardiac
dysfunction and by antagonizing CXCR4 to inhibit cardiac mast cell infiltration and activation but without
affecting the suppressive effects of DOX on tumor growth. This hypothesis will be tested through specific
aims: 1) Optimizing the protective effects against DICT in tumor-free and tumor-bearing mice; 2) Determining
whether it prevents DICT through activating CXCR7/AMPK and prevents cardiac cell death and dysfunction; 3)
Determining whether it prevents DICT through inhibiting CXCR4-mediated cardiac mast cell infiltration and
activation. Successful completion of this project will reveal new insight into the underlying mechanisms behind
and provide fundamental evidence for it as a novel approach for preventing DICT in future clinical studies.

Public health relevance
The objective of this study is to validate an innovative concept that the unique dual TC14012 protects against doxorubicin-induced cardiotoxicity (DICT) by activating cardiac CXCR7 to reprogram cardiomyocyte metabolism and prevent cardiac dysfunction and by antagonizing CXCR4 to inhibit cardiac mast cell infiltration and activation in multiple mouse models. We will first optimize the doses of TC14012 for protecting against DICT in two tumor-free and tumor-bearing mouse models, and then we will determine its direct effects and mechanisms on energy reserve metabolism and mitochondrial function in cardiomyocytes and on cardiac mast cell infiltration and degranulation. This project will reveal new insight into the underlying mechanisms behind and provide fundamental evidence for TC14012 as a novel approach for the prevention of DICT in future clinical studies.